Cell surface receptor targeted therapies for brain tumors

SUMMARY
New therapeutic approaches are desperately needed for highly malignant brain tumors, glioblastomas (GBMs),
where standard therapy has shown limited to no efficacy. In our previous studies, we have developed mouse tumor
models of GBM resection and extensively demonstrated that engineered “off the shelf” mesenchymal stem cells
(MSC) encapsulated in biocompatible synthetic extracellular matrix (sECM) have therapeutic benefits post-GBM
surgery. Engineered T cell based therapies have demonstrated impressive clinical efficacy in hematological
cancers, however their success has been limited in solid tumors like GBM, particularly due to evasive and inhibitive
tumor micro-environment (TME) and chronic antigen triggering in the presence of suppressive signals in the TME. In
order to address the issues related to excessive engineering and exhaustion of T cells, we took advantage of the
homing and allorecognition avoidance properties of MSC and engineered them to release bi-specific T cell engager
(BITEs) consisting of nanobodies (vHH domain of a heavy chain antibody) simultaneously targeting over-expressed
EGFR and specifically expressed EGFRvIII variant in GBM and a CD3 specific scFv (MSC-ENb-BiTE). Our exciting
preliminary data indicate that MSC-ENb-BiTE redirect wild type blood derived untransduced T cells to tumors and
induce tumor regression in GBM mouse models. These results although promising, have raised fundamental
questions for our engineered MSC and naïve T cell therapeutic strategy to target multiple antigens and
simultaneously enhance the immunomodulatory function of T cells in mouse tumor models that mimic clinical
settings of resected GBM tumors and present nodular and invasive phenotypes? In this proposal, we will develop a
broad platform of MSC releasing BiTEs targeting EGFR/EGFRvIII and IL13Rα2 and twin (Tw)-BiTE that
simultaneously targets EGFR/EGFRvIII and IL13Rα2 and extensively test their therapeutic efficacy post
transplantation of sECM encapsulated MSC-BiTE/Tw-BiTE and intraventricular delivery of T cells in mouse GBM
models of resection. Based on the hypothesis that interleukin (IL)-12 will improve the potency of T cell therapy and
blocking PD-1 on recruited T cells will result in effective eradication of residual GBM cells, we will co-engineer MSC-
Tw-BiTE to express IL-12 and immune-check point inhibitor and assess their efficacy with T cells in GBM models of
resection derived from primary GBM lines representing distinct tumor nodular and invasive phenotypes. To ease
clinical translation, we will assess the mechanism underlying efficacy of encapsulated engineered MSC and T cells
in humanized mouse GBM models. The integration of the kill switch in engineered MSC will ensure safety of our
approach and the incorporation of genetically engineered imaging markers into both MSC and GBMs will allow us to
follow fate and efficacy in vivo and thus to fine tune the proposed approaches. We anticipate that our findings will
have a major contribution towards developing novel cellular therapies for GBM and are likely to define a new
treatment paradigm for patients with other cancers.

Public health relevance
NARRATIVE: In this proposal, we will assess the mechanism based therapeutic efficacy mesenchymal stem cells expressing bispecific T cell engagers (BiTEs) and T cells in GBM models in vivo. The developed agents and strategies will be designed to be clinically translatable and should have a major impact in translating cell based therapies for a broad spectrum of tumors.